The Function of Antimalarial Drug Resistance Proteins

Project Summary
Malarial parasite sensitivity to chloroquine (CQ) as well as important artemisinin combination therapy (ACT)
partner drugs (notably piperaquine [PPQ], amodiaquine [AQ], and lumefantrine [LF]) and are affected by
mutations in the P. falciparum transporter PfCRT. Of the 61 known distinct PfCRT protein isoforms discovered
since 2000, some mediate emerging or evolving phenotypes selected for by relatively recent changes in front-
line antimalarial drug therapy. In drug resistant parasites, PfCRT protein harbors 4 to 10 amino acid
substitutions relative to wild type. These confer most of the ~ 10-fold shift in CQ IC50 seen for common CQ-
resistant (CQR) strains, with milder, variable resistance to other drugs often observed in these strains.
However, only a handful of the isoforms have been studied in molecular depth. The Dd2 (Asia/Africa) and 7G8
(S. America) isoforms both confer CQR, but 7G8 PfCRT confers lower CQR and also mediates AQR. Recent
data shows some rare mutant PfCRTs may not confer drug resistance at all.
This project brings together expertise in protein biochemistry, transporter physiology, reverse genetics,
and structural biology by leveraging the established expertise of the Roepe (Georgetown), Fidock (Columbia),
Chang (UCSD), and Stowell (U.C.,Boulder) laboratories to comprehensively define how new mutant isoforms
of PfCRT influence currently evolving antimalarial drug resistance.
We have three aims: 1) we will use novel and previously validated antimalarial drug probes, engineered yeast
strains and purified recombinant protein to unambiguously define function of PfCRT isoforms expressed in
evolving P. falciparum resistant to both quinoline – based (chloroquine; CQ, piperaquine; PPQ) and Artemisinin
– based drugs, 2) we will characterize reverse engineered strains of P. falciparum expressing PfCRT isoforms
that are created in specific P. falciparum genetic backgrounds, in order to isolate and characterize the precise
contribution of PPQR-associated PfCRT function to evolving phenotypes, and 3) we will leverage our
considerable progress with purification of PfCRT, highthroughput production of PfCRT specific nanobodies,
cryoEM methods, molecular dynamics, and other physical chemical approaches to significantly expand recent
collaborative success at defining atomic level structure of PfCRT isoforms.

Public health relevance
Project Narrative Mutations in the pfcrt gene has been linked to resistance to antimalarial drugs, and at least 61 PfCRT protein isoforms have been found across the globe. This project quantitatively compares the function of novel PfCRT isoforms associated with a new form of drug resistance (“MDRdcp”), using yeast and malarial parasite model systems, and will solve structures of these proteins via cryoEM and synthetically evolved nanobody (SEN) methods.